2023 Microbial Adhesion and Signal Transduction Gordon Research Conferences and Seminar

ABSTRACT
The Gordon Research Conference on Microbial Adherence and Signal Transduction is a premier international
scientific conference that brings together researchers with a shared interest in understanding the diverse
mechanisms bacteria have evolved to interact with the environment, each other and with animal hosts. The
meeting is held biennially at Salve Regina University in Newport, Rhode Island. The 2023 meeting will be held
July 15-21 and will have an associated Gordon Research Seminar to (i) provide students and postdocs a basic
background in the concepts, principles, and mechanisms involved in different areas of microbial adhesion and
signal transduction; (ii) promote the interaction of junior investigators with their peers and selected senior
members of the field (keynote speaker and discussion leaders); (iii) provide feedback on their research, thereby
sharpening their presentation skills and the sophistication of their discussions in preparation for the main meeting
and beyond. The GRC will focus on scientific questions of how microbes sense, respond, colonize, and
eventually spread in both the environment and in host organisms. Attendees will include an equal distribution of
independent investigators, post-doctoral scholars, and graduate students. Genetic, biochemical, cell biological,
immunological, ecological, evolutionary and structural biology approaches will all be represented. There will be
nine seminar sessions with session leaders that will provide an overview of the topic and stimulate discussion
from the attendees. The 2023 meeting will be organized by Chairs Raphael Valdivia (Duke University, NC) and
Melanie Blokesch (Swiss Federal Institute of Technology Lausanne, Switzerland) and the elected vice-chairs
Fitnat Yildiz (University of California Santa Cruz, CA) and Tracy Palmer (University of Newcastle, UK). This
meeting provides a forum where cutting edge research will be presented on the mechanisms controlling bacterial
adherence and signal transduction. There are slots reserved in thematic seminar sessions for presentations by
postdoctoral fellows and graduate students, giving them an opportunity to share their discoveries and gain
exposure at a high-impact international conference. The GRS will be co-chaired by Zachery Lonergan (California
Institute of Technology, CA) and Anne Sophie Stolle (University of Münster, Germany), who were elected by the
participants of the 2019 GRS. This meeting provides an environment that enables networking and collaboration
among investigators and early career scientists, which gives post-doctoral researchers and graduate students
access to influential leaders in the field of microbial adherence and signal transduction. The program includes
many new principal investigators that have not previously presented their research at this meeting, and includes
new sessions that reflect the multi-disciplinary approaches being used to address emerging questions of seminal
importance in the field.

Public health relevance
NARRATIVE The primary goals for the 2023 Gordon Research Conference and Gordon Research Seminar on Microbial Adherence and Signal Transduction meeting are to promote the exchange of ideas and vigorous discussion on emerging themes on the mechanisms by which bacteria adhere, sense and respond to surfaces; and to facilitate interactions and collaborations between junior and senior researchers of diverse backgrounds. The critical role of adherence as the first step of infection and colonization makes it a frequent target for antibacterial strategies and thus aligns with the NIAID mission to understand, treat and prevent infectious diseases.